NPETE'S Community College Consortium for Health & Safety

The National Partnership for Environmental Technology Education (NPETE), ME,
submits this proposal on behalf of the Community College Consortium for Health and Safety
Training (CCCHST) to provide memorable, cost-effective training for hazardous materials and
waste workers engaged in waste treatment, storage and disposal, hazardous waste generation,
clean up and remedial action, emergency response and hazardous materials transportation.
CCCHST membership consists of community and tribal colleges partnered with business and
industry, universities, government agencies and community-based organizations offering a
consistent and quality response to the national training need for hazardous waste workers and
emergency response personnel.
The goal of CCCHST is to make NIEHS-approved worker training nationally available
through over 100 CCCHST organizations, whose instructors are prepared through a Train-the-
Trainer model program, the GreatEST (Great Environmental Safety Trainers Institute), to offer
hazardous materials instruction in nearly all states of the nation. CCCHST instructors, prepared
and supported by PETE, will annually train a minimum 30,000 students, workers, and
supervisors to protect themselves and their communities from exposure to hazardous materials
encountered during hazardous waste site cleanup, Brownfields redevelopment, transportation of
hazardous materials, and response to spills and releases of hazardous materials, offering a
minimum 3,000 courses each year. PETE has two additional missions beyond its core Train-
the-Trainer model program.
(1) Military Haz Mat Worker Training. PETE will offer a direct worker training program
for Total Military Family (TMF) personnel, including veterans, military personnel and their
families transitioning to the public sector. Annually, a minimum 600 TMF members from across
the nation and internationally will receive a variety of OSHA certifications by Zoom. Three
bases including Fort Riley (KS), Fort Sill (OK) and Fort Carson (CO) will receive a total of four
face-to-face 40-hour Waste Site Worker program annually.
2) PETE’s Disaster Preparedness Instructor Institute will annually prepare up to 20
CCCHST and partner trainers, including those from other NIEHS-awardees, who serve a wide
variety of students and responders. These trainers will return to their communities to annually
prepare an additional 1,500 responders in the Gulf, the South and Midwest, U.S. Territories,
Tribal Nations, programs serving CERT and Americorps students, and responders throughout
the U.S.

Public health relevance
The goal of the Community College Consortium for Health and Safety Training (CCCHST), sponsored by the National Partnership for Environmental Technology Education (NPETE), is to help the nation be better prepared to prevent and respond to hazardous materials incidents through the training of instructors serving workers from business and industry; students from community and tribal colleges. technical schools, and alternative schools; first responders; transitioning military; and members of community-based and faith-based organizations in targeted communities. CCCHST will make NIEHS-approved training nationally available through over 150 CCCHST members, prepared through a Train-the-Trainer model program, to offer hazardous materials and disaster preparedness instruction in nearly all states of the nation and its territories. Over 150,000 workers, students, and citizens, prepared by CCCHST instructors over a five-year period, will understand how to protect themselves and their communities when working with hazardous chemicals and hazardous situations.